Administrative Core

ABSTRACT
The overall goal of the Center is to derive a biologically plausible model for human thalamus function by
identifying and modeling functional organization principles of higher-order thalamic computations and
interactions between thalamus and cortex. The goal of Core A is to provide administrative support to all center
projects and cores and coordinate their activities under the leadership of Dr. Kastner. This includes plans to
facilitate information transfer and data sharing among projects and cores, to disseminate knowledge gained by
Center activities to the scientific community and public (including a comprehensive educational outreach
program), and to provide training and professional development opportunities. The Center comprises five
projects and two cores led by eight PIs/Co-Is from eight institutions, who represent a wide range of methods and
expertise including multimodal neuroimaging in neurotypical and clinical human populations, and intracranial
electrophysiology in non-human primates and tree shrews. The close collaborative links and synergy across the
projects and cores that will be critical to the success of the proposed Center necessitate a high level of scientific
and administrative oversight and coordination across the different Center components. Core A will have the
following aims: 1. To provide oversight over all scientific activities of the Center components by facilitating
communication through regular Center meetings of the Steering Committee (comprised of the Center Director
and all PIs/Co-Is), the whole Center community, and the external consultants, and by establishing an External
Advisory Board, in consultation with NIH; 2. To provide oversight over all administrative responsibilities such as
the budget and resource allocation, annual reporting and maintaining a Center website; 3. To provide training
opportunities, particularly considering underrepresented minorities, and to develop an educational outreach
program.